The Helicobacter pylori VacA Receptor Binding Site

SUMMARY
This exploratory R21 application seeks to identify and characterize the molecular basis by which the
Vacuolating Cytotoxin (VacA), which is the only known intracellular-acting exotoxin secreted by the human
gastric pathogen Helicobacter pylori (Hp), recognizes and binds to host cells as a requisite step for host cell
intoxication. Chronic infection with Hp is the single most important risk factor for gastric adenocarcinoma, the
third leading cause of cancer-related deaths worldwide. Nearly all Hp isolates harbor vacA, which has been
demonstrated to be important for colonization in a murine model of Hp infection. Relevant to this application,
specific polymorphisms within vacA correlate with both toxin cellular activity and the severity of Hp-associated
diseases. In particular, a region located in carboxyl-terminal domain of VacA, known as the “middle (m)
region”, segregates into two allelic variants, m1-VacA, which is associated with higher risk of disease, and
more potent cellular modulatory activity, and m2-VacA, associated with lower risk of gastric disease, and less
potent cellular modulatory activity. Although incompletely understood, several studies have suggested that
m1-VacA and m2-VacA may differ in host cell receptor specificity, which is a critical determinant of toxin cell
tropism. Moreover, results from extensive phylogenetic analyses suggest that the m1- and m2- forms of VacA
may possess different cellular activities that bestow a selective advantage for maintaining both alleles in the
human population. Previous studies in the PI’s laboratory identified the abundant plasma membrane surface
sphingolipid, sphingomyelin (SM), as an important determinant for m1-VacA binding to the cell surface of host
cells as an important determinant of toxin cellular activity. Moreover, in vitro experiments indicate that VacA
preferentially binds to SM over other common membrane lipids. These and other findings support our overall
hypothesis that SM functions as a cell surface receptor for m1-VacA. Nonetheless, essentially nothing is
known about how VacA recognizes and binds to the toxin’s sphingolipid receptor. Moreover, it is not currently
known whether SM-dependent toxin cell surface binding and cellular activity, which we discovered to be
associated with m1-VacA, are properties that extend to m2-variants of the toxin. This application proposes
studies to address these gaps in knowledge in the context of two inter-related, but not co-dependent Specific
Aims. In Aim 1, we propose to identify the SM-receptor binding site of m1-VacA, using both biochemical and
computational approaches. In Aim 2, we will extend these approaches to evaluate whether the importance of
cell-surface SM for m1-VacA, extends also to m2-VacA. Completion of these exploratory studies will address
for the first time whether SM-receptor dependent cell binding and activity is a shared characteristic of both
m1- and m2-toxin allelic variants, and will provide the framework for future studies to not only better
understand both the molecular basis and consequences of VacA allelic variation, but also set the stage for
structure-based inhibitor development to block the very earliest stages of VacA cellular intoxication.

Public health relevance
PROJECT NARRATIVE Chronic infection with the human pathogen, Helicobacter pylori (Hp), is a major risk factor for several important diseases, including stomach cancer. The only protein toxin secreted from Hp, which is called the Vacuolating Cytotoxin, assists the bacterium in establishing infection within the stomach and contributes to the severity of gastric disease. Studies to identify the detailed mechanism by which this toxin interacts with and enters gastric cells will, not only provide additional insights into how Hp infection leads to gastric disease but will also provide necessary clues for future work to mitigate the effects of the toxin during bacterial infection within the human stomach, using structural-based drug design, building upon knowledge obtained from completing the studies proposed in this application.